(PQC2) Resistance to fluid shear stress: a novel biomarker of cancer cells

DESCRIPTION (provided by applicant): Unique biomechanical and biophysical features of cancer cells represent a relatively untapped potential source of biomarkers for the detection, diagnosis and monitoring of therapeutic response in cancer patients. These distinct cancer cell phenotypes may integrate a number of the molecular abnormalities driving cancer into discrete, quantifiable biomarkers that could, in principle, be more consistent and straightforward to assess than the complex genetic landscape in this disease. It has recently been shown that cancer cell lines from numerous tissues in suspension exhibit resistance to brief pulses of high level fluid shear stress (FSS) compared to normal or benign epithelial cells. This phenotype reflects signaling through at least several common oncogenic pathways. The objective of this proposal is to determine if resistance to FSS is a biomarker with clinical diagnostic potential in animal models of prostate cancer and tissue from human melanoma subjects. The central hypothesis of this proposal is that resistance to fluid shear stress is a conserved biophysical property of cancer cells that is associated with disease progression and can be used to predict response to therapy. The rationale for the proposed research is that once it is determined that FSS resistance is associated with pathologic progression of disease, and/or response to molecularly targeted therapies these findings can be translated into a novel clinical diagnostic paradigm for prognostic assessments or predicting early failure or prolonged response not possible with conventional approaches. The specific aims of this proposal are: 1) Determine if resistance to FSS is associated with prostate cancer progression in animal models; and 2) Determine if resistance to FSS is associated with drug sensitivity in tissue from human melanoma subjects. The contribution of this proposal will be significant because it will test the concept that FSS resistance is a clinically relevant biomarker worthy of further study and development. This proposal employs a simple microfluidic assay to measure FSS resistance in two separate experimental paradigms, one animal-based, one in human tissue. It is anticipated that increased FSS is associated with disease progression and decreased FSS corresponds to drug sensitivity. The proposed research is innovative because it represents a rapid and simple means to assess the response of a population of cancer cells to mechanical force (FSS) in suspensions that can be readily prepared from clinical specimens. The transformative potential of this work is that it may provide an alternative paradigm to molecular diagnostics.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to the mission of the NCI because it seeks to develop a novel clinical diagnostic paradigm based on measurement of a biophysical biomarker, resistance to fluid shear stress, in cancer cells. These studies will have broad applicability to many types of cancer, but will most immediately benefit prostate cancer, in which there is a significant unmet need for prognostic biomarkers, and melanoma, where FSS resistance may be used to predict therapeutic response. This approach is a substantive departure from established techniques and has distinct advantages: speed, simplicity, applicability to clinically obtainable specimens, and assessment of cell populations that favor its translational potential. __SpecificAimsTextDelimiter__ (PQC2) Resistance to fluid shear stress: a novel biomarker of cancer cells Specific Aims Unique biomechanical and biophysical features of cancer cells represent a relatively untapped source of biomarkers for detection, diagnosis, and monitoring of response to therapy in cancer patients. Molecular biomarkers for these purposes have yielded some successes to date, but the underlying molecular complexity and heterogeneity of cancer has hampered progress with this approach. In contrast, biomechanical and biophysical properties of cancer cells may integrate a host of molecular aberrations we know are present in cancer cells into quantifiable phenotypes that can be more easily accessed and measured, in essence, de- convoluting cancer's inherent molecular complexity and providing a more consistent biomarker across many tumor types. We recently discovered such a biomarker in cancer cells, resistance to fluid shear stress (FSS). However, both the biological significance and potential of this biomarker as a clinical diagnostic approach have not been explored. Our long term goal is to understand the mechanisms underlying FSS resistance in cancer cells and its diagnostic potential in cancer patients. The objective of this proposal is to determine if resistance to FSS is a potential clinical biomarker in animal models of prostate cancer and tissue from human melanoma subjects. The central hypothesis of this proposal is that resistance to FSS is a conserved biophysical property of cancer cells that is associated with disease progression and can be used to predict response to therapy. Our hypothesis has been formulated on the basis of our recent findings that cancer cells exhibit a characteristic biphasic survival response when exposed to a series of millisecond pulses of high-level FSS. This phenotype distinguishes transformed cells from benign cell types, depends on an active physiological response of the cells involving extracellular calcium uptake and actin cytoskeletal dynamics, and it is specifically conferred by several common oncogenic signaling pathways including ras, myc and PI3K. The rationale for the proposed research is that once we determine that FSS resistance is associated with pathologic progression of disease, and/or response to molecularly targeted therapies we will be able to translate our findings into a novel clinical diagnostic paradigm for prognostic assessments or predicting early failure or prolonged response not possible with conventional approaches. We will test our central hypothesis and accomplish the objective of this application by pursuing the following two specific aims: 1) Determine if resistance to FSS is associated with prostate cancer progression in animal models. Based on our preliminary data, we have determined that FSS resistance can be measured in cancer cells acutely dissociated from mouse prostate tumor tissue. Our working hypothesis is that FSS resistance will increase with pathologic progression in mouse models of prostate cancer progression. 2) Determine if resistance to FSS is associated with drug sensitivity in tissue from human melanoma subjects. Our preliminary data shows that inhibitors of the ras-raf-MEK-ERK pathway decrease resistance to FSS. Our working hypothesis is that melanoma cells dissociated from excised tumor tissue treated with vemurafenib (an inhibitor of mutant BRAF) or other inhibitors of this pathway will decrease FSS resistance in a manner dependent on BRAF mutational status. The expected outcome of this research is to validate the concept that resistance to FSS is a novel biophysical biomarker with the potential to provide prognostic information about tumor progression and potential early response assessments to molecularly-targeted therapies. Such results would have an important positive impact because they would support the development of a new rapid and simple clinical diagnostic approach that could enhance patient management decisions in prostate cancer, melanoma and other malignancies. The transformative potential of this work is that it may provide an alternative paradigm to molecular diagnostics.